Establishing an Evidence Base to Increase the Utility of Urine Drug Testing in Opioid Use Disorder Treatment.

Project Summary/Abstract
Urine drug testing (UDT) is an integral component of opioid use disorder (OUD) treatment, and is often required
by payers for patients treated with medications for OUD (MOUD). These regulations exist despite a lack of
evidence-based guidelines. There is no consensus about the optimal UDT frequency, what drugs to test for,
when to use different types of tests (e.g., presumptive versus definitive), and how to adapt care when patients
test positive for non-prescribed substances. Inconsistent practices have important public health and clinical
implications, as they can contribute to either missed opportunities to improve care or to the misallocation of
clinical resources. The goal of this grant is to identify variation in real-world use of UDT that can be modified by
clinical guidelines and policy change, and to examine the patient- and clinician-level factors that influence the
application of UDT, and their relationship with processes of care. Aim 1 will characterize distinct trajectories of
UDT use during episodes of OUD treatment nationally, and across patient characteristics, clinicians, payers,
and states. The sample will comprise continuously enrolled patients with diagnosed OUD from 2015-2022 from
a national, multi-payer database that tracks patients across disparate data systems and includes service claims
data linked to laboratory results. We will examine the correlates of testing frequency and type across different
groups of interest. Aim 2 will identify distinct trajectories of drug positivity during OUD treatment episodes and
identify variation across groups. We will identify the prevalence of patients testing positive for common non-
prescribed drugs (e.g., opioids, cocaine) at the beginning of treatment episodes and the persistence of positivity
in the treatment episode. Using latent class analysis, we will group patients into subtypes related to patterns of
drug positivity (e.g., persistently abstinent, transitioning to abstinence, persistently positive). Aim 3 will estimate
the association between trajectories of UDT use, substance positivity, and process of care measures in the
episode (e.g., retention, MOUD adherence, hospitalization). Using Aims 1-2 variables, we hypothesize that
greater UDT use will not generally lead to changes in process of care outcomes and that patients who are
persistently positive for substances will have worse process of care outcomes. Aim 4 will examine perspectives
of clinicians to identify perceptions and practices related to UDT use. We will survey a national sample of
clinicians treating OUD recruited from a drug testing laboratory. They will be asked about their knowledge,
attitudes, and practices related to testing. From this group, we will conduct qualitative interviews with 30
clinicians who vary in their testing practices to learn more about potential opportunities to inform decision-
making surrounding UDT in clinical practice. Overall, this study will characterize the variation in UDT use in real-
world clinical practice and help identify the potential scope for UDT to positively change processes of care for
patients. The findings will lay the foundation for developing pragmatic clinical trials, informing policy decisions,
and refining clinical practice.

Public health relevance
Project Narrative Urine drug testing (UDT) is an integral aspect of opioid use disorder treatment, yet no universal standards exist for how it should be used in clinical practice. The lack of clear guidance may result in inappropriate testing or missed opportunities to guide clinical care. The purpose of this project is to examine the use of UDT in a large, real-world population and assess the attitudes, knowledge, and practices of clinicians who order UDT.